Shared Resources Core 1: Genomics/Epigenomics Core

PROJECT SUMMARY (MAJEWSKI)
Mutations in histone and modifier genes in cancers have dramatic downstream effects on the landscape of the
epigenome – chromatin state and DNA methylation – with eventual secondary outcomes manifested in gene
expression and cellular phenotypes. Modern functional genomics approaches provide invaluable tools to study
the effects of this epigenome-mediated cascade. In this Core activity, we will establish and provide a set of
genomics tools and computation methods to elucidate the mechanisms through which histone variants impact
the epigenome, transcriptome, and the cell identity during neoplastic transformation.

Public health relevance
PROJECT NARRATIVE (MAJEWSKI) Cancer progression is associated with massive global aberrations of genome and epigenome organization. Modern genomics technologies have provided invaluable new insights into molecular mechanisms of cancers, including the discovery by our team members of the histone mutations that are the subject of this proposal. The establishment of this Core will provide team members with state of the art genomic and computational tools to unravel the mechanisms of action of histone mutations.